Training in Cardiac Magnetic Resonance Imaging

DESCRIPTION (provided by applicant): The Department of Electrical Engineering, working with researchers in the School of Medicine, has had a long and successful history in collaborative medical imaging research and in medical imaging training of a large number of predoctoral students. In this renewal application, we seek to continue our program in training electrical engineering predoctoral students in the area of cardiac magnetic resonance imaging (MRI). MRI has achieved great success in imaging many regions of the body and is poised to make a significant impact in cardiac imaging. With its many challenges, this field provides an outstanding vehicle for research training of predoctoral students in medical imaging. Predoctoral students in this training program will have abundant access to imaging equipment, and to both technical and clinical personnel. We propose to enhance our program through the training of three predoctoral students in cardiac MRI. Based on our track record of predoctoral student training, we strongly feel that this program will not only provide an excellent base but also lead to significant contributions to the field of cardiac MRI.

Public health relevance
Project Narrative There is a need for researchers with a background in cardiac medical imaging technology and applications. The proposed training program with predoctoral students in electrical engineering at Stanford University addresses this need. These students will receive training in the growing field of cardiac magnetic resonance imaging. These students will work with a closely knit group of technical and clinical preceptors with access to a wide range of imaging equipment.